Genetic resiliency to disease progression in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is marked by impaired cognition and memory loss. AD patients also exhibit 5–10-fold
increased incidence of seizure activity compared to age-matched controls, with one study finding 42%
experienced subclinical epileptiform activity using extended EEG monitoring. Epileptiform activity predicts more
severe cognitive decline, and treatment with antiseizure drugs slows cognitive decline. Notably, there are
individuals who exhibit AD neuropathology on autopsy despite exhibiting normal cognition, referred to as non-
demented with AD neuropathology (NDAN). The mechanisms by which NDAN individuals maintain intact
cognition are unknown, although social interaction is associated with reduced risk of dementia in older adults.
Transgenic mice overexpressing mutant human amyloid precursor protein, which causes overproduction of Aβ
(APP mice, Line J20), also exhibit subclinical epileptiform and seizure activity, with a subset demonstrating
“resilience” similar to NDAN individuals. Around 30% of APP mice stop having seizure activity and develop
normal spatial memory by 3-4 months of age, despite having comparable levels of Aβ and seizure history to
“susceptible” APP littermates, who exhibit worsening memory and continued seizure activity. To stratify mice as
resilient or susceptible, we use ΔFosB expression in the dentate gyrus (DG) as a proxy, as we have previously
published ΔFosB as an excellent marker of chronic hyperexcitability, with the magnitude of ΔFosB expression
corresponding directly with both seizure frequency and spatial memory deficits. Resilient APP mice have ΔFosB
levels similar to NTG littermates, while susceptible APP mice express significantly more ΔFosB. To investigate
differences between resilient and susceptible APP mice, we examined an RNA-seq dataset generated using DG
samples from resilient and susceptible APP mice and NTG littermate controls. We identified 73 genes as
“resilience genes”, as differential expression was only observed in resilient mice relative to NTG and susceptible
mice. Of the resilience genes identified, I further examined oxytocin receptor (Oxtr), given its high AGORA score
(suggesting relevance to human AD) and oxytocin’s role in promoting social behaviors, as social isolation is a
risk factor for AD. Oxytocin has also been implicated in reducing seizure activity and improving spatial memory
in mouse models of epilepsy and AD, respectively. Preliminary data indicated that resilient APP mice exhibit
increased oxytocin signaling to the hippocampus. Notably, chronic oxytocin treatment in APP mice reduced
ΔFosB levels to near NTG levels, suggesting oxytocin may confer resilience to APP mice. To investigate the role
of oxytocin in resilience to AD progression, I will 1) characterize the natural time course of changes in oxytocin
signaling in resilient APP mice and investigate underlying mechanisms, and 2) determine necessity and
sufficiency of oxytocin signaling in conferring resilience to AD progression. By identifying underlying genetic
mechanisms conferring this natural resilience, we can target these pathways for exogenous manipulation in an
effort to artificially confer resilience to AD progression.

Public health relevance
PROJECT NARRATIVE A subset of individuals exhibits resilience to Alzheimer’s disease, as indicated by significant Alzheimer’s disease neuropathology on autopsy despite intact cognition. Underlying pathways that engage this resilience remain largely unknown, making it difficult to develop targeted therapies that harness these naturally-occurring pathways. My goal is to investigate genetic mechanisms of natural resilience, so that we can design strategies that leverage these underlying mechanisms to therapeutically confer resilience to Alzheimer’s disease progression.